Novel functions of ESRRB in glioblastoma

Glioblastoma (GBM) is the most lethal of all brain malignancies and many patients die within one year of
diagnosis. These poor outcomes are driven by GBM's aggressive growth, local invasion, and both de novo and
rapid development of radiotherapy and chemotherapy resistance. GBM uses alternative splicing to generate
unique mRNAs and proteins that promote its proliferation and invasion. Here, we investigate specific alternative
splicing programs and will test if their manipulation has the potential to reveal novel therapeutic strategies to
oppose the aggressive biology of this deadly disease. Estrogen-related receptor beta (ESRRB) is an orphan
nuclear receptor - it is not bound by estrogen. Upregulated expression and increased ESRRB gene copy number
are both associated with longer overall GBM survival. The beta2 isoform of ESRRB is produced by alternative
splicing, with current evidence implicating serine/arginine-rich splicing factor 6 (SRSF6) as a key driver of this
event. Beta2 activation by the synthetic ESRRB agonist DY131 induces apoptosis in GBM cells. Beta2 localizes
to the cytoplasm and interacts with cortactin, an actin binding protein that increases cell motility by controlling
actin remodeling and vesicle trafficking. Importantly, the synthetic ESRRB agonist stabilizes beta2/cortactin
interaction, leading to loss of GBM cell motility, effects we propose are linked to the antitumor effect of beta2. In
this proposal, we hypothesize that the beta2 isoform of ESRRB acts as a potent inhibitor of GBM by interacting
with cortactin to inhibit motility/invasion. We further propose that pharmacological upregulation/activation of
beta2 may ultimately offer a novel approach to GBM therapy. In Specific Aim 1, we will test if SRSF6 promotes
ESRRB splicing to increase beta2 expression levels, and if direct upregulation of beta2 by SRSF6 inhibits GBM
motility/invasion. We will complement these focused, mechanistic studies by testing two novel splicing
modulatory drugs for their ability to increase beta2 production in GBM. In Specific Aim 2, we will identify how
the beta2/cortactin interaction inhibits GBM motility. Specifically, we will test if beta2 suppresses GBM motility
by inhibiting cortactin-mediated actin branching and remodeling, and vesicular trafficking in GBM. In parallel, we
will perform an unbiased screen to identify other novel cytoplasmic binding partners of beta2, and test their role
in suppressing GBM motility. While this grant is focused on foundational mechanistic studies, they will provide
powerful preclinical evidence for a future novel therapeutic strategy for GBM. The long-term impact of
successfully establishing a new treatment regimen that upregulates and activates beta2 would be a major benefit
to the field, in which 1) the current first-line standard of care (surgery, concurrent temozolomide + radiotherapy,
adjuvant temozolomide) has remained essentially unchanged for nearly 20 years, and 2) there is no widely
accepted second-line standard of care.

Public health relevance
Glioblastoma (GBM) is the most deadly of all brain tumors, and many patients die within one year of diagnosis. Our proposal will identify how the beta2 isoform of the nuclear receptor ESRRB, which is expressed at higher levels in longer-term GBM survivors, works as a potent inhibitor of GBM. These studies will provide powerful preclinical evidence for a future novel therapeutic strategy for GBM.